12th Annual Nursing Research Conference 2016: Transforming Nursing Practice through Research and Dissemination

? DESCRIPTION (provided by applicant): 12th Annual Nursing Research Conference: Transforming Nursing Practice through Research and Dissemination Abstract The purpose of this conference grant submission is to obtain financial support for the 12th Annual Nursing Research Conference: Transforming Nursing Practice through Research and Dissemination. The primary goal of this conference is to provide a forum to promote clinical nursing research regionally, nationally, and internationally. A secondary goal, but one that is equally important, i to provide a relaxed, non-threatening environment in which clinical nurses interested in nursing research are surrounded by other nurses who have conducted research studies and changed practice based on their findings. Unlike other nursing research conferences, this conference is specifically planned to meet the needs of the clinical nurse who is in a unique position to identif clinical problems in need of a solution. Grant funding is being sought to expand the influence of this clinical nursing research conference. Last year, calls for abstracts, announced on national and international nursing websites, resulted in 95 abstracts received from nurses at 30 different organizations representing 14 states and 5 countries and, after peer review, 60 abstracts were accepted for poster presentations and 19 abstracts were accepted for oral presentations. Several conference innovations, such as live web-streaming to remote locations and one-on-one research consultations, begun in 2015 will be expanded in 2016. Registration for 2015 was 325 and in 2016 it is expected to exceed 350.

Public health relevance
PUBLIC HEALTH RELEVANCE: 12th Annual Nursing Research Conference: Transforming Nursing Practice through Research and Dissemination The first step to implementing important new healthcare discoveries is often the presentation of clinical research findings at a professional conference for consideration by colleagues and healthcare stakeholders. Clinical nurses who are involved in research are in a unique position, poised to identify clinical problems and lead investigations that have the potential to improve practice. However, clinical nurses often lack the time and financial support needed to attend costly conferences where their findings can be presented to the scientific community. The Office of Nursing Research and Innovation at the Nursing Institute of the Cleveland Clinic has been sponsoring a unique, affordable nursing research conference for the past eleven years in order to provide a forum to promote nursing research and provide education and encouragement for the clinical nurse involved in nursing research. In order to continue the mission of pushing nursing research forward and advancing evidence-based practice, this conference attracts clinical nurses and nurse researchers from across the country and around the world. The plans for the12th Annual Nursing Research Conference are to continue a two-day conference that includes nationally recognized nurse researchers as keynote speakers, at least 60 poster presentation, 20 oral research presentations and 16 educational sessions. In addition we would like to expand our live stream to include more than one remote conference location in 2016. However, with institutional cost-cutting measures in effect, financial support is needed to promote this invaluable forum and continue to disseminate nursing research and education that can rapidly contribute to better healthcare for all Americans. An AHRQ (R 13) small conference grant will allow us to continue to expand and grow as a forum and voice for clinical nursing research.